Consequences of HELQ alterations in alcohol and tobacco-related cancers

Project Summary / Abstract
Tobacco smoke and alcohol, alone or in combination, are associated with an increased risk of cancers
including head and neck cancers and lung cancer. Tobacco smoke contains formaldehyde. The metabolism of
alcohol releases acetaldehyde. These aldehydes can form DNA-protein and DNA-DNA crosslink adducts,
induce genomic instability, and promote cancer. The repair of these DNA crosslink adducts is an important
defense against damage from tobacco smoke and alcohol. Mutations in the genes involved in repair of these
lesions may be associated with tobacco and alcohol-related cancers.
HELQ is a candidate gene to investigate for two reasons: 1) HELQ is involved in DNA crosslink repair.
We found that disruption of HELQ in human cells enhances chromosome aberration and cellular sensitivity
when exposed to DNA crosslink-inducing agents, and that HELQ associates with the Fanconi anemia (FA)
proteins FANCO (RAD51C) and FANCU (XRCC2). The FA pathway is crucial for DNA crosslink repair; and 2)
Two independent genome-wide association studies pinpointed the same polymorphism in HELQ as one of the
top hits associated with head and neck cancers and lung cancer, particularly amongst heavy alcohol drinkers
and tobacco smokers. Further, we have found that one point mutation found in lung cancer is a ubiquitin
modification site, and that it influences subcellular localization. However, it is not known whether HELQ
processes DNA crosslink damage in the FA pathway. It is also not known whether cancer-associated
alterations influence HELQ activity and cellular sensitivity to DNA crosslink-inducing agents.
Our central hypothesis is that HELQ functions in the FA pathway and that some mutations and
polymorphisms in the HELQ gene alter crosslink repair, leading to increased susceptibility to tobacco and
alcohol-related cancers. Guided by preliminary data, this hypothesis will be tested by pursuing two specific
aims: 1) Identify effects of HELQ alterations on chromosome aberration and cellular sensitivity upon exposure
to crosslink-inducing agents, and the genetic relationship of HELQ with the FA pathway; and 2) Determine
biochemical activity of HELQ derivatives on DNA crosslink adducts. Under the first aim, an already proven
RNA interference (RNAi) approach will be used to deplete FA genes in our established HELQ knockout human
cell lines. Under the second aim, we have purified wild-type HELQ and are ready to generate cancer-
associated HELQ variants.
The approach is innovative, because HELQ is a newly identified DNA crosslink repair protein and
expected outcomes for our proposed studies will identify previously unexplored aspects of DNA crosslink repair
in human cells. The proposed research is significant, because once it is known how HELQ and its alterations
influence crosslink repair, specific HELQ mutations and polymorphisms can be developed as biomarkers,
resulting in innovative risk assessment approaches to the prevention of tobacco and alcohol-related cancers.

Public health relevance
Project Narrative Two independent genome-wide association studies pinpointed the same polymorphism in HELQ as one of the top hits associated with head and neck cancers and lung cancer, particularly amongst heavy alcohol drinkers and tobacco smokers. HELQ is important for repair of DNA damage, but the functional consequences of cancer-associated HELQ alterations remain unknown. The proposed research is relevant to public health because the discovery of the effects of cancer-associated alterations in HELQ including this polymorphism is expected to increase understanding of the mechanism of alcohol and tobacco-related cancers, as well as risk prediction for such cancers.